Cholesterol homeostasis in the vertebrate retina

ABSTRACT:
All eukaryotic cells require cholesterol (Chol) for survival, and regulate their steady-state levels by balancing de
novo synthesis, uptake of Chol-containing lipoproteins, and Chol efflux (i.e., “Chol homeostasis”). Our current
understanding of Chol homeostasis in the retina remains rudimentary. Hereditary defects in Chol synthesis
comprise a family of severe, often lethal, metabolic disorders, e.g., Smith-Lemli-Opitz Syndrome (SLOS).
SLOS involves defective conversion of 7-dehydrocholesterol (7DHC) to Chol, which is catalyzed by DHCR7 (7-
dehydrocholesterol reductase). Treating rats with a DHCR7 inhibitor (e.g., AY9944) causes progressive,
irreversible retinal degeneration: the photoreceptors (PRs) preferentially degenerate and die, and RPE cells
also exhibit autophagy/heterophagy defects. However, off-target effects of DHCR7 inhibitors cannot be
obviated, and no viable genetic mouse models of SLOS are available. We have generated two novel, viable,
conditional allele models of SLOS, allowing targeted ablation of either Dhcr7 exon 8, or separately exon 9, to
partially or completely block DHCR7 in selective cell types and tissues. We hypothesize that de novo Chol
synthesis by retinal neurons alone is insufficient to maintain their viability and functionality; rather, they rely
upon Chol uptake from blood-borne (liver-derived) lipoproteins, Müller glia, and/or the RPE to meet their sterol
demands. Also, that disruption of normal Chol homeostasis provokes defective phagolysosomal biology in the
RPE and retina. We will test our hypothesis as follows: In Aim 1, we will selectively knock out Dhcr7 in rod
PRs and, separately, in Müller glia (or in tandem) and then assess the impact on sterol composition of outer
segments and optic nerve, as well as retinal structure/function; in Aim 2, we will generate panretinal knock-out
(KO) of Dhcr7 or, separately (and in tandem), in liver (hepatocytes) and then assess the impact on sterol
composition retina, liver, and blood. Using these resources, and a stable isotope approach, we will estimate
retinal sterol synthesis, uptake and turnover rates; and in Aim 3, we will use RPE and liver-specific Dhcr7 KO
mice to assess the effect of de novo 7DHC synthesis and its uptake on RPE phagocytic function. We will
model the observed SLOS RPE pathology using patient iPSC-derived RPE cells (multiple clones, with
appropriate controls), and screen for candidate drugs to improve the observed EMT and phagocytic defects.
We will use novel in vivo assays using a tandem-tagged autophagy reporter mouse model to systematically
elucidate the role of Chol synthesis in retinal phagolysosomal biology. The results obtained will significantly
advance both our fundamental understanding of Chol homeostasis in the vertebrate retina and mechanisms
underlying retinal pathology associated with Chol synthesis defects, and provide new tractable model systems
for future testing of more effective therapeutic interventions for SLOS and related orphan diseases.

Public health relevance
PROJECT NARRATIVE The retina, like most other tissues, maintains a physiologically optimal concentration of cholesterol by balancing local (de novo) cholesterol synthesis, vs. uptake from extraretinal sources (e.g., blood-borne lipoproteins, generated in the liver) and export— a process called “cholesterol homeostasis”. Dysregulation of this process leads to profound pathologies, such as Smith-Lemli-Opitz syndrome (SLOS), which can compromise retinal structure and function. This project seeks to further define how cholesterol homeostasis is achieved by the retina, utilizing a combination of novel, genetically altered mice (where cholesterol synthesis has been blocked in a cell type-specific manner) and in vitro cell culture studies (using SLOS patient-derived RPE cells, which exhibit defective autophagy), and to test candidate drugs that can rescue the autophagic defect, as a prelude to testing their ability to rescue retinal degeneration in the novel mouse models of SLOS to be generated.